MASTER AGREEMENT FOR CHEMICAL SYNTHESIS

The objective of this Master Agreement is the synthesis of specific organic and inorganic compounds, required by DTP, for confirmation testing. The specific compounds shall be competed under MAO/RFPs to be issued at a later date.